HEPARIN IN TREATMENT OF ULCERATIVE COLITIS

This study evaluates Heparin in the treatment of ulcerative colitis. This study also attempts to define the hypercoaguable state that accompanies flares of ulcerative colitis.